Administrative Core: Self-Managment Science Center at UWM

Programs and interventions exist that address self-management for chronic conditions these programs and interventions are not framed in a comprehensive theory that includes the complex interactions between the contexts in which individuals and families live and the processes for skills and abilities of self-management, which are not fully identified, and how these two components influence adoption of self-management behaviors. The purpose of this application in response to the RFA-NR-14-001 for Centers of Excellence in Self-Management: Building Research Teams for the Future is to enhance and sharpen the focus of the Self-Management Science Center at UWM to individual and family self-management of chronic conditions. The Specific Aims of the SMSC are to: 1) Select and support pilot studies that advance the science of self-management for individuals and families with or at high risk for chronic conditions across the lifespan; 2) Expand and refine research to better understand the components of the Individual and Family Self-Management Theory (IFSMT) as they apply to chronic conditions; 3) Synthesize the contribution to science from studies using the Individual and Family Self- Management Theory; and, 4) Expand the capacity for building research teams with a focus on self-management through collaborations interdisciplinary scientists, partner institutions, and community networks of individuals and families. The Administrative Core will have the oversight for all the activities of the SMSC.

Public health relevance
The Self-Management Science Center at UWM will address critical issues that have an impact on our ability to improve health outcomes of diverse populations. The burden of chronic illness for individuals, families and society remains as a major concern for public health and the containment of healthcare costs.